Role of the Entorhinal Cortical Delta Oscillations in Systems Consolidation

Project Summary / Abstract
Memory consolidation, a crucial step in memory formation that creates long-lasting engrams in the neocortex
using labile memory created during waking, is severely impaired in Alzheimer’s disease. Memory consolidation
occurs via two levels: Cellular consolidation, which stores new information via strengthening synapses in the
hippocampus within hours of learning, and systems consolidation, which creates long-term memory in the
neocortex via large-scale communication between the hippocampus and the neocortex. It has been shown that
this large-scale communication is mediated by oscillatory activities in the hippocampus known as sharp-wave
ripples (SPW-Rs), which are coordinated by slow oscillations and sleep spindles in the neocortex. The entorhinal
cortex has extensive connections with the hippocampus and is the earliest region impacted by the pathogenesis
of Alzheimer’s disease even before the hippocampus or neocortex are affected. Yet, there is a fundamental gap
in understanding the role of entorhinal cortical oscillations in systems consolidation. Our published and pilot data
provide compelling evidence that delta oscillations generated by temporoammonic (TA) pathway neurons, which
project from the entorhinal cortical layer III to the hippocampal output area CA1, play a crucial role in the
formation of long-term explicit memory. However, neither the circuit mechanism underlying the role of the
entorhinal cortex in memory consolidation nor the role of the TA pathway in systems consolidation is yet known.
The proposed studies will examine the role of delta oscillations of the TA pathway (“TA delta”) in mediating cortical
feedback on the hippocampus during systems consolidation using cell-type specific optical recordings,
electrophysiology, monosynaptic tracing, optogenetics, chemogenetics, and rodent behavioral testing. The
proposal focuses on the following three questions: (1) Does TA delta modulate hippocampal SPW-Rs? (2) How
is TA delta modulated by neocortical inputs from the anterior cingulate cortex? (3) Does TA delta play a crucial
role in integrating new information with the cortically consolidated remote memory? Completion of these studies
will elucidate the key mechanism underlying cortical communication to the hippocampus mediated by TA delta
during systems consolidation, which would unravel a new mechanism underlying the impairment of memory
consolidation shown in Alzheimer’s disease.

Public health relevance
Project Narrative The entorhinal cortex is among the most severely degenerated regions in Alzheimer’s disease; yet, the circuit mechanism underlying the role of the entorhinal cortex in memory consolidation remains unclear. This project aims to determine the role of entorhinal cortical oscillations in cortical communication to the hippocampus during systems consolidation at the circuit and behavioral levels. The outcome of this study would make a significant advancement in understanding the impairment of memory consolidation in Alzheimer’s disease, which is central to the development of therapeutic interventions.